SAFETY OF BMS 186716 IN THE TREATMENT OF HEART FAILURE

The benefits of ACE inhibition in chronic heart failure have been confirmed in many studies. Angiotensin converting enzyme (ACE) catalyzes the transformation of angiotensin I to angiotensin II, a hormone with antinatriuretic, vasoconstrictor and growth enhancement actions. The combination of ACE with Neutral endopeptidase (NEP) in the treatment of hypertension and heart failure will be studied.